Linking specific phosphorylation events to distinct transcriptional states

Abstract: Linking specific phosphorylation events to distinct transcriptional states
The cellular behaviors that underlie health and disease are directed by signal transduction pathways that drive
gene expression. Linking signaling to specific gene expression is a fundamental goal of biology. Our ability to
identify causal links between specific phosphorylation events and the expression of certain genes would not only
better our comprehension of cellular decision-making, but would reveal a breadth of novel points of therapeutic
intervention for us to modulate cell functions and behaviors. We propose an innovative data-driven technology
solution through integrating global, temporally-resolved transcriptomic and phosphoproteomic data with
statistical modeling to systematically identify of signaling events predictive of context-specific gene sets. We will
validate the predicted links between phosphosites and specific gene expression programs employing novel
CRIPSR-mediated base editing technology to mutant individual phosphorylation sites at endogenous loci to
assess their impact on gene expression at an unprecedented scale, as well as corroborate using conventional
methods. As a model system, we will focus on cytokine induced signaling and gene expression in macrophages,
which are critical modulators of inflammation. Specifically, we will interrogate the cytokines IL-6 and IL-10, which
signal through common Janus kinases (JAKs) and signal transducers and activators of transcription (STAT)
transcription factors to promote contrasting pro- and anti-inflammatory functions, respectively. We will explore
the hypothesis that signaling events occurring outside of the JAK/STAT axis encode cytokine-induced
transcriptional diversity and can be targeted to modulate context-specific cytokine induced genes. Successful
completion of this proposal will provide a robust experimental and computational framework to identify and
perturb key phosphorylation events, and measure the specificity of signaling-to-transcription links that shape the
diversity of cellular responses. The workflow developed here will be broadly applied across a variety of stimulus,
cellular, and disease contexts, improving efficiency of the therapeutic development pipeline.

Public health relevance
Project Narrative Understanding how signal transduction pathways drive specific genetic circuits is a fundamental goal of biology. The thousands of dynamic signaling events and gene expression changes that occur upon cell stimulation have made linking these two processes challenging. Here, we propose a novel, interdisciplinary analytical framework to link gene expression programs to specific phosphorylation events using genome-wide data with the goal of expanding strategies for therapeutic intervention.